Zinc Supplementation in SCD: A Precursor to the Think Zinc for Bones Trial

Abstract
Patients with sickle cell disease (SCD) experience early onset bone morbidity; 60% of young adults with SCD
live with low bone mass and are at increased risk for fracture. Zinc, an essential trace mineral, is crucial for red
cell stability, growth, and bone metabolism. Zinc deficiency is reported in approximately 40% of young patients
with SCD and has been related to poor growth, increased vaso-occlusive episodes, and decreased bone
density. The etiology of zinc deficiency in SCD is multifactorial, including inadequate dietary intake, increased
requirements due to escalations in red cell turnover, and elevated urinary losses from renal insufficiency. Our
underlying hypothesis is that that zinc supplementation can ameliorate the steady deterioration of
bone mass and structure in individuals with SCD. Though vitamin D has received much attention, zinc is
perhaps more important for bone health, particularly for patients with SCD. In a previous interventional trial, we
demonstrated that zinc supplementation increased bone density in patients with thalassemia, a
hemoglobinopathy with similar bone deficits. Meta-analyses reported that zinc supplementation has the
potential to improve growth and reduce the number and severity of sickle cell-related pain episodes. Yet, most
of the reviewed studies are small, short-term, and single-center and none of the prior trials focused on bone
outcomes. A Cochrane Review concluded that large, multi-center, long-term zinc supplementation trials
focused on disease outcomes in sickle cell disease are needed. Although much attention has been paid
recently to curative therapies for patients with SCD, very few patients will have access to these new
therapeutics. Currently, no therapies in SCD focus on bone morbidity. The findings of this proposed research
could lead to a new, low-cost adjunctive therapeutic paradigm that will improve the lives of individuals with
SCD. Our investigative team demonstrates expertise to conduct a randomized multicenter nutritional study in
SCD. The ASH Research Collaborative Clinical Trials Network is poised to facilitate such an interventional trial,
and the patients with SCD and their families have expressed enthusiasm for participation in nutritional studies.
This R34 phase is crucial for the follow-up UG3/UH3 funded study by obtaining data to: (1) clarify optimal
skeletal sites to be studied by DXA imaging, (2) calculate more definitive sample size for the subsequent larger
study, (3) establish an effective yet tolerable zinc dose, and (4) develop quality control imaging and blood
collection protocols. The information gathered from this R34 study is indispensable for designing a robust,
multi-center randomized clinical trial within the ASH Research Collaborative Clinical Trials Network. By
determining these critical parameters, we will significantly enhance the likelihood of conducting a successful
and scientifically rigorous larger ASH Research Collaborative Network UG3/UH3 funded study focused on
bone response to zinc supplementation.

Public health relevance
Project Narrative This project aims to provide preliminary data on the most robust skeletal site to measure as well as an effective yet tolerable zinc dose to use within the proposed future randomized clinical trial of zinc on bone health in individuals with sickle cell disease (SCD). The successful completion of this pilot will also produce much- needed information for a more definitive sample size and furnish the opportunity to standardize bone imaging and blood collection protocols across the participating sites in the network. This information is necessary to ensure a successful multi-center randomized UG3/UH3 funded clinical trial of zinc supplementation on bone health, executed within the American Society of Hematology Research Collaborative Clinical Trials Network.